Resolving phenotypic overlap in renal carcinoma subtypes using multi-tiered network methods

PROJECT SUMMARY/ABSTRACT
Small sample size in Translocation Renal Cell Carcinoma (tRCC), a rare cancer, hampers our ability to
correctly diagnose this aggressive subtype and to provide patients with efficient therapies. The most important
causes of tRCC misdiagnosis are its heterogenous presentation and overlap with other subtypes such as the
major subtype, clear cell RCC (ccRCC), both of which contribute to making tRCC the most aggressive RCC in
both primary and metastatic forms. Previous studies have shown that tRCC is initiated by alterations in
regulatory elements (i.e., transcriptions factors, TFs) including a translocation at the TFE3 locus with a variable
partner gene, which triggers cancer progression. However activity of these TFs has not been systematically
identified. The goals of this work are to characterize subtype-specific gene regulatory elements in tRCC by
identifying differentially active TFs, determining their metabolic functions, and genetic variants controlling their
activity. In Aim 1, Dr. Ben Guebila will develop an optimization method that uses TF binding data and gene
expression to estimate context-specific TF activity profiles in tRCC. This method will be based on a constrained
optimization approach that uses prior domain knowledge to guide statistical inference and will enable inference
using small sample size for rare cancer. Applications of this method using RNA-Seq data in tRCC cell lines will
inform activity of TFE3 fusion protein and its implication in oncogenic processes. In Aim 2, Dr. Ben Guebila will
build a predictive metabolic network for tRCC cell lines to model various translocation types in TFE3 and
inform heterogeneity in tRCC presentation. This model will be then used to identify subtype-specific metabolic
pathways activation and find metabolic vulnerabilities that can be exploited as drug targets. In Aim 3, Dr. Ben
Guebila will further characterize genetic variants associated to activity of altered TFs in tRCC to determine
variable response (including resistance) to recently developed drugs that target these TFs. By developing
methods for three network types (transcriptional, metabolic, regulatory), results from this project will allow us to
improve diagnosis of tRCC, provide a better molecular definition using multi-omic data, and predict response
for newly approved FDA compounds using patient genotype. These research aims are supported by a team of
experts in regulatory genomics who will mentor Dr. Ben Guebila’s in five training goals: 1) genomics of kidney
cancer subtypes, 2) multiplex network inference, 3) statistical and population genetics, 4) statistical methods
for prior knowledge integration, and 5) career development. The institutional environment at Harvard T.H. Chan
School of Public Health and Dana-Farber Cancer Institute provide a unique opportunity for developing multi-
disciplinary projects at the interface of cancer genetics, network science, and translational medicine. This
award will equip Dr. Ben Guebila with the knowledge, skills, and training to pursue impactful and independent
research in computational oncology.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health as it will identify the genetic factors that contribute to misdiagnosis and drug resistance of a rare kidney cancer subtype, which remains an unmet clinical need. Previous studies have shown genetic alterations in regulatory elements (i.e., transcriptions factors, TFs) that drive its progression, but changes in TF activity that mediate its histologic and molecular overlap with other kidney cancer subtypes have not been systematically identified. In this project, we will develop computational methods to estimate activity of these regulatory elements and explore their role as a source of heterogeneity and overlap with other subtypes, infer their metabolic activity, and assess genetic variants that control their activity as potential pharmacogenetic markers of drug efficacy.